Massachusetts Institute for Equity-Focused Learning Health System Science (MIELHSS)

Overall Project Summary
Never in our lifetimes has there been a greater collective focus on health or the need to address the wide
disparities we face as a country in health outcomes. The Massachusetts Institute for Equity-Focused
Learning Health System Science (MIELHSS) brings together an alliance of FQHCs, Safety Net Hospitals,
Community Clinics, Patients, PCORnet sites, and leading academic health systems who share a common
purpose to accelerate research and train the future workforce to advance learning health system science,
address disparities, and improve health outcomes for the U.S. The overarching objective of MIELHSS is to
develop scientists in embedded research, and accelerate innovation in human-centered, equity-focused learning
health system (E-LHS) science. Our framework for training and learning is based on the quintuple aim of
healthcare: better health, improved patient experiences, care team wellbeing, and health equity, at lower cost.
We will develop future research leaders who can lead progress toward that goal. Our proposed curriculum,
experiential activities, mentorship, partnerships, data, and programming provide the core competencies required
to generate these innovative leaders in E-LHS science. Our specific aims are to: 1) Advance the development
of a diverse workforce of embedded E-LHS scientists across the professional development lifecycle; 2)
Accelerate enduring advancement in E- LHS science by adopting common data standards across a broad and
diverse network of equity measures and social determinants of health; and 3) Forge a strong cross institutional
alliance between community, safety net, academic health systems, patients, mentors, and scholars to drive
widespread and enduring change. Our team has strong working relationships and deep and complementary
experience across LHS Core Competencies and PCORI research, mentoring and training scholars including
LHS scholars, and a shared commitment to addressing health equity for all. We will provide tailored training
experiences across the professional lifecycle, community-wide engagement activities, data integration, methods
development, and proactive dissemination to accelerate the spread of successful E-LHS research. We will
measure success using traditional academic measures such as grant submissions and publications but also by
measuring health system engagement in MIELHSS activities and sustained implementation and widespread
adoption of interventions identified through this work.

Public health relevance
Overall Project Narrative The overarching goal of the Massachusetts Institute for Equity-Focused Learning Health System Science (MIELHSS) is to train embedded health system scientists and accelerate the conduct of equity-focused PCOR/CER to improve health system operations, quality, and health outcomes. Our group includes several large academic health systems, FQHCs, community centers, safety net hospitals, PCORnet sites, and the VA; together we care for diverse populations and share a common goal to advance equity-focused learning health system science. Our proposed infrastructure will: 1) create a stimulating environment to develop embedded LHS scientists from diverse backgrounds, 2) build a robust shared data structure that will support and accelerate equity-focused research, and 3) accelerate the collaborative culture change that will be needed to drive meaningful impact in LHS and health equity.